Prevention Research Center on Nutrition and Physical Activity

PROJECT SUMMARY/ABSTRACT
The mission of the Prevention Research Center on Nutrition and Physical Activity at the Harvard TH Chan
School of Public Health is to work with community partners to develop, implement, evaluate, and disseminate
cost-effective strategies that will improve population nutrition and physical activity, prevent excess weight gain
and chronic disease, and advance health equity. The current proposal will address significant gaps in
translating evidence-based healthful eating and physical activity interventions into practice and key health
promotion and disease prevention objectives in Healthy People 2030. These gaps represent critical needs
noted by our local health agencies and partners. Our implementation research project focuses on improving
healthful eating and physical activity behaviors (HEPA) among children (0-5 years) in early childhood
education (ECE) settings. Our proposed center and collaborative implementation research represent
opportunities to improve child health in Massachusetts, prevent future disease, improve health equity, and
disseminate results statewide and nationally. Our Aims are to: Establish and maintain the Prevention Research
Center infrastructure and partnerships needed to conduct applied prevention research to improve nutrition and
physical activity behaviors, prevent chronic disease, and improve health equity via sustainable policy, systems,
and environmental changes; 2) Identify and deliver equity-centered adaptations for an evidence-based
intervention (EBI) focused on promoting HEPA for child care settings serving 0-5 year-olds to improve its
uptake, impact, and sustainability in under-resourced settings using implementation science methods in
collaboration with local health agency and community partners; and 3) Collaborate with the PRC network to
implement a collective impact approach to leverage PRC network members' expertise, partnerships, and
leadership to advance health-equity focused public health prevention research. We will engage with community
partners to develop, communicate, and disseminate products and knowledge from our research and build
community capacity with partners to foster uptake and sustainability. Completing these actions will increase
our capacity to bridge the gap between public health research and practice, creating knowledge to improve
health and reduce health inequities.

Public health relevance
PROJECT NARRATIVE The proposed project will enable the Prevention Research Center on Nutrition and Physical Activity at the Harvard T.H. Chan School of Public Health to engage with partners working in public health practice at the local, state, and national levels to promote the translation of evidence-based interventions to improve nutrition and physical activity behaviors, prevent chronic disease, and improve health equity via sustainable policy, systems, and environmental changes. Our implementation science research project will identify and deliver equity-centered adaptations for an evidence-based intervention focused on promoting healthful eating and physical activity for child care settings serving 0-5 year-olds to improve its uptake, impact, adoption, and sustainability in under-resourced settings in collaboration with local health agency and community partners and the PRC Network.